Understanding the Nature and Regulation of Extramedullary Hematopoiesis in the Liver

Project Summary/Abstract: Hematopoietic stem cells (HSCs) play a vital role in the immune system by
generating both innate and adaptive immune cells. My career objective is to lead a laboratory investigating
the intrinsic and extrinsic factors that regulate HSC function and the intricate interplay between HSC biology
and immunology, with the ultimate aim of improving the treatments for immunity-related diseases. One
intriguing aspect of HSCs is their ability to leave the bone marrow (BM) in adult organisms and initiate
extramedullary hematopoiesis (EMH) in the liver. While EMH was traditionally considered a compensatory for
insufficient BM hematopoiesis, emerging evidence shows that EMH also plays a critical role in the progression
of diverse diseases, such as tumorigenesis and heart failure, and is also implicated in trained immunity.
However, our knowledge about how the HSCs in the EMH liver are cell-intrinsically and -extrinsically regulated
remains limited, which represents a critical knowledge gap for its understanding and manipulation under
various pathological processes. In this proposal, I will address this gap by pursuing three specific aims: Aim
1: I will characterize the cellular components of the HSC niche in the EMH liver, focusing on revealing the
functional source of two critical cytokines for HSC maintenance, SCF and CXCL12; Aim 2: I will identify
whether and which subset of HSC clones initiating liver EMH by utilizing a novel CRISPR/Cas9-mediated
barcoding mouse model in combination with multimodal single-cell sequencing; Aim 3: I will investigate the
role of HSC-autonomous Rbfox2, an alternative splicing regulator, in regulating liver EMH formation. The
gained insights are expected to have broader applications in understanding and manipulating the progression
of various pathological processes. During the K99 phase, my research will be conducted in Dr. Lei Ding's
laboratory at Columbia University. Dr. Ding is a pioneer in the field of HSC biology and has made significant
contributions to revealing the cell-intrinsic and -extrinsic mechanisms regulating HSC function and
hematological disorders. To differentiate my research from Dr. Ding's work and enhance my expertise in
immunology for my long-term research pursuit, I will receive additional mentorship from my co-mentor Dr.
Sankar Ghosh, a distinguished immunologist. I have also assembled an advisory committee consisting of
experts in liver biology (Dr. Robert Schwabe), epigenetics (Dr. Chao Lu), CRISPR/Cas9 technology and
bioinformatics (Dr. Xuebing Wu), and career development (Dr. Jaime Rubin) to expand and enhance my
experimental and professional skills. Furthermore, I will leverage the extensive facilities and resources
available at Columbia University. With these supports, I will acquire additional experimental techniques,
advance my expertise in bioinformatics, and refine my skills in grantsmanship, mentoring, lab management,
and scientific communication, which are instrumental for me in establishing a research niche separate from
my mentor's and successfully transitioning from a postdoctoral researcher to an independent investigator.

Public health relevance
Project Narrative Hematopoietic stem cells (HSCs), typically located in the bone marrow in adult organisms, can migrate to the liver to initiate extramedullary hematopoiesis (EMH). This proposal aims to understand how the HSCs in the EMH liver are cell-extrinsically and -intrinsically regulated. The gained knowledge is expected to offer a comprehensive understanding of liver EMH applicable to manipulating various pathological processes.